PharmGKB: pharmacogenomics discovery and implementation

7. Project Summary
Pharmacogenomics studies how genetic variation influences drug response phenotypes and is a pillar of
precision medicine—choosing the right drug for the right patient at the right dose and time. A public resource
of pharmacogenomics information is critical—both to catalyze basic discovery of the molecular mechanisms
that drive variability in drug response and to support the implementation of clinical research to understand how
to best deliver pharmacogenomics in the clinic. The Pharmacogenomics Knowledgebase (PharmGKB) is the
premier public repository of pharmacogenomics information. PharmGKB curators focus on high quality
extraction and representation of knowledge in the primary literature, and capture information about individual
genetic variations that impact drug response, the potential clinical impact of these variations, the
pharmacokinetic and pharmacodynamic pathways of drug response, the pharmacogenomic requirements in
regulatory documents (labels), and guidelines for genome-driven prescribing. The PharmGKB website hosts
more than 60,000 unique IP visits per month and provides flexible access to pharmacogenomics knowledge on
multiple devices. Most importantly, PharmGKB serves as a hub for the research community in
pharmacogenomics and precision medicine—integrating its contents with critical resources and organizations
including ClinVar, ClinGen, the FDA, the Clinical Pharmacogenetics Implementation Consortium (CPIC) and
others. In this proposal, we request support for PharmGKB as a Genomic Community Resource, and outline a
plan to (1) curate pharmacogenomic knowledge from the published literature and from relevant databases,
combining manual curation with automated methods for triaging important knowledge, (2) build tools that
catalyze the discovery and use of pharmacogenomic knowledge, by providing the content of our knowledge
base in novel ways useful to our users, and (3) collaborate with efforts devoted to implementation of genomic
medicine, by providing the best scientific knowledge to support these efforts.

Public health relevance
8. Project Narrative Drug response is inherited in much the same way as other traits like height, hair color, and the risk for some diseases. Pharmacogenomics studies how human genetic (DNA) variation influences the response to drugs. The PharmGKB resource aims to catalog all the human variation that impacts drug response, so that individual genetic data can be used to choose drugs for the individual that are more likely to work, and less likely to cause side effects.